The Role of Xist in T Cell Activation and Female-Biased Autoimmunity

PROJECT SUMMARY
Approximately 80% of individuals affected by autoimmune disease are female. While divergent sex hormones
and chromosomes are known to contribute to sex bias, the roles of additional sex-specific factors are poorly
understood. Xist, for instance, is a long non-coding RNA (lncRNA) expressed exclusively in females. Notably,
Xist is more highly expressed in PBMCs from females with autoimmunity compared to healthy controls,
suggesting a possible role for Xist in predisposing females to autoimmunity. Xist is a key regulator of X-linked
gene expression, facilitating X chromosome inactivation (XCI) during early embryonic development. Recent work
has identified Xist-mediated regulation of autosomal genes, a previously unappreciated Xist function, in cell types
with atypical, dispersed Xist distribution. We and others have noted atypical, dispersed Xist in activated CD4+ T
cells, an immune cell type critical in autoimmune pathogenesis. To study Xist in T cells and autoimmune
pathogenesis, we engineered mice with T cell-specific Xist knockout. Preliminary studies reveal Xist-deficient
CD4+ T cells are defective in proliferation and proinflammatory cytokine production, suggesting a critical role for
Xist in T cell activation. However, the (1) mechanism by which Xist alters T cell effector function and (2)
significance of Xist-driven phenotypic changes for autoimmune pathogenesis are not known. This proposal will
test the hypothesis that Xist drives X-linked and autosomal chromatin accessibility and gene expression
changes that support a proinflammatory T cell phenotype and contribute to female bias in autoimmunity.
In Aim 1, we will perform ATAC-, RNA-, and RAP-sequencing in unstimulated and anti-CD3 stimulated Xist-
deficient and WT CD4+ T cells to explore the mechanisms by which Xist regulates T cell effector function. In Aim
2, we will evaluate the role of T cell-intrinsic Xist in autoimmune pathogenesis using a mouse model of the
female-biased, T cell-driven autoimmune disease, Sjogren’s Syndrome (SS). These studies will elucidate Xist
function in T cells and explore T cell-intrinsic Xist as a potential determinant of female bias in
autoimmunity. This work is guided by experts in T cell biology (Maureen Su, MD - sponsor; Gay Crooks, MD -
thesis committee), lncRNA biology (Kathrin Plath, PhD - cosponsor), bioinformatics (Willy Hugo, PhD -
collaborator), and sex differences in biology (Karen Reue, PhD – thesis committee) at the University of California
Los Angeles. The trainee, Nicole Wilkinson, is richly supported for the work in this proposal and in reaching her
career goal of running a translational immunology lab.

Public health relevance
PROJECT NARRATIVE Autoimmunity predominantly affects females, but the mechanisms of sex bias remain incompletely understood. Xist is a female-specific long non-coding RNA (lncRNA) shown in recent work and our preliminary studies to modulate lymphocyte effector responses. In this proposal we evaluate the (1) mechanism by which Xist modulates T cell activation and (2) role of T cell-intrinsic Xist in female-biased autoimmunity.